Manganese Based MRI Contrast Agent

Gadolinium (Gd)-based MRI contrast agents (GBCAs) are used in clinical magnetic resonance imaging (MRI)
for cancer detection and staging, particularly of primary and metastatic brain cancers. However, there are
concerns about the potential long-term toxicity of GBCAs. GBCAs cause nephrogenic systemic fibrosis (NSF),
a devastating disorder that affects patients with kidney disease. FDA imposed a “black box” warning against
GBCA use in this population. This has a significant medical impact: 16% of US adults suffer from moderate or
severe chronic kidney disease (CKD), and this patient population is disproportionately afflicted with comorbidities
like cancer (where many chemotherapies are nephrotoxic). There is no alternative imaging for these patients.
Contrast enhanced CT can cause acute and irreversible kidney injury and is also contraindicated. All GBCAs
cause accumulation of Gd in the brain and bone, even in patients with normal kidney function. Gd is highly toxic
in its free form, and little is known about the toxicological implications of deposited Gd: concern is rising among
physicians, patients, and regulatory agencies. In 2017 the FDA announced a new class warning for all GBCAs.
The European Medicines Agency suspended the marketing authorizations for the 4 GBCAs that are associated
with the highest risk of Gd deposition, and arguably may have removed all GBCAs had there been a safe, Gd-
free alternative. Accumulation of Gd is particularly worrisome for cancer survivors and those at high risk for
cancer, e.g. BRCA positive women. They require regular GBCA-enhanced MRIs for surveillance or screening,
and may have dozens of MRIs through life. Avoiding GBCAs forces physicians to make key patient management
decisions with limited imaging information, while continued use may put these vulnerable patients at risk.
Reveal Pharmaceuticals is developing the gadolinium-free MRI contrast agent, RVP-001, invented at
Massachusetts General Hospital. RVP-001 provides equivalent image contrast to commercial GBCAs in different
animal models. Manganese (Mn) injected as RVP-001 is more efficiently eliminated than Gd from an equal dose
of Gd-DOTA, which is considered the best in class GBCA for safety with respect to stability. Nonclinical studies
established a very high safety margin for RVP-001. A Phase 1 study to assess safety, tolerability, and
pharmacokinetics in healthy subjects demonstrated that RVP-001 is safe and well tolerated up to doses higher
than the anticipated clinical dose. This grant will support first in human MR imaging studies. We will perform a
dose range finding study in patients with GBCA-enhancing central nervous system lesions, e.g. brain cancers,
to assess imaging efficacy, pharmacodynamics, and safety. We will assess the degree of RVP-001 lesion
enhancement compared to unenhanced MRI and compared to the patient’s GBCA enhanced MRI. The goal of
the study is to establish an effective dose for further clinical development and approval.
This grant application is predicated on the Fast Track NIH grant award R44 DK113906-03 and is a
resubmission of the grant application 9 R44 CA261240-04

Public health relevance
Project Narrative Gadolinium based contrast agents (GBCAs) are used with MRI to detect and stage cancers and other diseases and to guide treatment. However there are safety concerns about the potentially toxic gadolinium metal ion. We have invented a gadolinium-free contrast agent to replace GBCAs. The goal of this proposal is to test the safety and imaging efficacy of this new agent RVP-001 in patients with brain cancer or other brain disorders.